Core B: Data Management and Analysis Core (DMAC)

ABSTRACT: DATA MANAGEMENT AND ANALYSIS CORE (DMAC)
The Data Management and Analysis Core (DMAC) provides critical support for UNC-SRP researchers to
manage, analyze, and disseminate data related to the theme, “to protect vulnerable populations from arsenic-
induced disease using mechanistic and translational solution-oriented research.” The goal of the DMAC is to
facilitate the data management, sharing, integration, and analysis needs of UNC-SRP researchers to elucidate
multi-factorial determinants of iAs-induced metabolic dysfunction/diabetes. The DMAC is housed the UNC
Department of Statistics, Department of Environmental Sciences and Engineering, and the Renaissance
Computing Institute, representing programs that are uniquely suited to lead in data management, statistical
analysis, integration, and dissemination of findings produced from the UNC-SRP team of Projects and Cores.
All researchers across the UNC-SRP work closely with the DMAC for data science, statistical support,
bioinformatic analysis, visualization, and dissemination needs. The DMAC is uniquely fitted to facilitate the data
management and analysis needs of Biomedical Projects, generating a broad suite of data types that includes
iAs-associated genomic and epigenomic signatures, bacterial presence/abundance in the gut, and phenotypic
outcomes. The DMAC has additional data management and analysis expertise to guide Environmental Projects,
to analyze iAs levels in NC, geospatial factors of iAs prediction mediators, economic analysis projections, and
metrics of iAs reduction via water treatment. The DMAC will provide training with the Research Experience and
Training Coordination Core (RETCC) for the management, analysis, and dissemination of these diverse data
types, in close collaboration with the Community Engagement Core (CEC) to promote community feedback and
engagement in action. Specific aims of the DMAC include: (1) Implementation of the UNC-SRP-wide
comprehensive Data Management and Sharing (DMS) Plan to include high quality data generation and systems
that foster sharing and interoperability; (2) Support of UNC-SRP research activities by applying state-of-the-art
bioinformatic and biostatistical approaches within each Project; (3) Integration and dissemination of data across
UNC-SRP Projects to elucidate risks of iAs exposure and disease mechanisms. Together, the DMAC provides
the UNC-SRP with essential expertise in data management, bioinformatics, statistics, data integration, and
dissemination that contribute to the team fulfilling its mission to develop new solutions for iAs reduction and
disease prevention through mechanistic and translational research.

Public health relevance
NARRATIVE: DATA MANAGEMENT AND ANALYSIS CORE (DMAC) The overarching goal of the Data Management and Analysis Core (DMAC) is to facilitate the data management sharing, integration, and analysis needs of UNC-SRP researchers to elucidate multi-factorial determinants of iAs-induced metabolic dysfunction/diabetes. All UNC-SRP Projects and Cores will work closely with the DMAC to ensure maximal impact of all data produced through UNC-SRP research. The DMAC will support the identification and dissemination of high impact insights surrounding metabolic disease/diabetes and iAs exposure, geospatial predictions of iAs exposure classification, and remediation efforts.